Optimization of Helicobacter pylori-related Disease Outcomes in Veterans

The PI is a physician-scientist and gastroenterologist whose long-term career goal is to independently
lead a respected, multidisciplinary research program that is keenly focused on personalizing Helicobacter
pylori (H pylori) management in order to optimize disease-, treatment-, and systems-related outcomes among
Veterans. This CDA-2 is designed to transform the PI into VA Merit-funded researcher with methodologic
proficiency in big data analysis, genetic epidemiology, and advanced epidemiologic methods, and scientific
proficiency in H pylori pathobiology. The PI is well-supported by mentors whose expertise and wealth of unique
resources quintessentially bridge her career and research objectives, and by deeply supportive and
collaborative institutions. The PI is committed to advancing Veteran health by providing exceptional patient
care at the bedside and by conducting cutting-edge, clinically relevant science.
H pylori is the strongest known risk factor for gastric cancer, a malignancy which claims over 780,000
lives annually and remains the 3rd leading cause of cancer-related mortality. This pathogen is also directly
causative for other diseases with high morbidity and mortality, including peptic ulcer disease. H pylori infects
approximately 28% of all Veterans, with the prevalence exceeding 50% among racial and ethnic
minorities. H pylori eradication necessitates 10-14 days of 2-3 antibiotics and high-dose acid suppression.
Successful eradication has led to a decreased incidence of gastric cancer and other diseases for which H
pylori is causative. However, rising rates of H pylori eradication failure threaten these successes and
contribute to the massive burden of antibiotic resistance and other adverse consequences, since eradication
failure is managed with repeated courses of therapy. Indeed, in 2017 the World Health Organization
designated H pylori eradication failure a research priority area, which speaks to its critical importance and
broad health impact. The reasons underlying eradication failure are multifactorial and, apart from antibiotic
resistance, have not been completely investigated.
We hypothesize that defining host-level determinants of eradication failure will maximize the initial
success of eradication by providing an anchoring point on which to develop a personalized approach to
therapy. We further hypothesize that a personalized approach will improve individual treatment response,
reduce the unintended downstream consequences of eradication failure and, consequently, improve H pylori-
related outcomes among Veterans. In this proposal, the PI will leverage two powerful VA databases, the
Corporate Data Warehouse (CDW) and the Million Veteran Program (MVP), the electronic health record-
linked genomic biobank, to first construct a cohort of Veterans from each database who completed H pylori
testing (approximately 10% of all Veterans based on preliminary data). A sub-cohort of Veterans who were
treated and had post-treatment H pylori testing to assess eradication success will also be constructed from
MVP specifically (~18,000 of the over 650,000 genotyped Veterans). Using these two cohorts, the PI will define
the prevalence of H pylori, the frequency and type of anti-H pylori therapy, select antibiotic resistance patterns,
the frequency of eradication failure as well as time trends and regional variations (AIM 1). This will be followed
by defining the genetic and non-genetic determinants of H pylori eradication failure using GWAS (AIM 2),
multivariable logistic regression and Mendelian randomization (AIM 3) study designs, respectively. Predictive
models for antibiotic resistance based on non-invasive data will also be constructed and validated. This work is
significant because it will fill critical knowledge gaps of H pylori epidemiology and treatment among Veterans.
In future prospective studies as an independent VA investigator, the PI will integrate host-level determinants of
eradication failure into a clinical support tool that can be translated to the bedside for personalization of H pylori
eradication therapy based on individual-level factors in an effort to optimize Veteran health.

Public health relevance
Helicobacter pylori causes gastric cancer and is the strongest known risk factor for this malignancy. H pylori infects an estimated 28-53% of Veterans. Risk factors for both disease-related complications due to persistent H pylori infection and treatment-related complications are over-represented in the Veteran population compared to the US civilian population. Defining host-level genetic and non-genetic determinants of eradication failure is critical to maximizing initial H pylori eradication success and minimizing the unintended downstream consequences of a failed therapeutic response. The deliverables from this CDA-2 will be: 1) immediately actionable data that will be used to personalize the therapeutic approach for Veterans who are infected with H pylori in order to optimize their individual responses to therapy, and 2) the transformation of a capable and talented early career investigator into a VA Merit-funded physician-scientist dedicated to improving H pylori outcomes among Veterans